Macrophages in steroid resistant asthma

PROJECT SUMMARY
Pediatric asthma is a chronic pulmonary inflammatory disease that is causes airway inflammation and
restricted airflow. Patients with severe asthma are resistant to steroid treatment, which leads to worsened
symptoms and exacerbations. While asthma is known to involve T-helper 2 (Th2) inflammation, recent studies
suggest steroid resistant asthmatics have a predominant Th1 inflammatory profile, involving IFNγ and Th1
lymphocytes. Although the adaptive immune response has been shown to mediate steroid resistance in asthma,
the contributions of the innate immune cells, such as macrophages are not well understood. Lung macrophages,
either classically- or alternatively-activated, are known to produce and secrete cytokines that are involved in Th2
and Th1 inflammation, making them highly relevant to asthma pathogenesis. Previous studies have shown that
macrophages have an important role in asthma, yet little is known about macrophage contributions to steroid
resistance and severe asthma. Using an augmented ovalbumin mouse model and primary mouse and human
macrophages, we will investigate macrophages and their contributions to airway inflammation, airway and
hyperresponsiveness in 2 Specific Aims. Studies in Aim 1 will determine the role of steroid resistant lung
macrophages in a mouse model of allergic airway inflammation using lung macrophage depletion and adoptive
transfer techniques. In Aim 2, this proposal will examine the mechanisms by which IRF5, a pro-inflammatory
transcription factor, disrupts glucocorticoid receptor signaling in classically-activated macrophages. These
studies will be conducted using cultured primary mouse bone marrow derived macrophages. To further assess
steroid resistant pathways in lung macrophages, RNA-seq analysis will be performed. Additionally, steroid
sensitivity will also be assessed in classically-activated human lung macrophages. Importantly, these studies are
supplemented with a comprehensive postdoctoral training plan that will enhance the scientific and professional
development of a promising postdoctoral fellow. The concepts and skills learned will provide a foundation for
future pathway to independence grants such as the K99/R00.

Public health relevance
NARRATIVE Pediatric severe asthma remains a significant problem for children characterized by increased asthmatic exacerbations, reduced quality of life, and limited response to current treatments. The overall goal of this proposal is to understand how the macrophages, an important immune cell, contribute to corticosteroid insensitivity. These studies will enhance the understanding of severe asthma and could lead to improved, more specialized treatment for children with asthma.